SIV zoonosis using humanized mice

Project Summary/Abstract:
The main goal of our proposed studies is to evaluate select SIVs for their potential for human transmission using
a humanized mouse (hu-mouse) human surrogate animal model. Cross-species transmission events give rise
to several deadly human pathogens including HIV-1 and HIV-2 and more recently SARS-CoV-2. While only four
HIVs have established themselves in human populations (HIV-1 group M, HIV-1 group O, HIV -2 groups A and
B) outbreaks, there were many other lesser ones, namely HIV-1 group P and N and HIV-2 groups C through I,
indicating that SIV transmissions to humans are not infrequent events. More than 40 SIVs exist in the wild in
non-human primates (NHP) in West and Central Africa and human encroachment into their habitat continues to
accelerate, suggesting that potential for the emergence of new human pathogens still exists. Thus, we need to
be vigilant and conduct viral surveillance. In this context, animal models that can permit testing of SIV cross-
species transmission and evolution are needed. For this purpose, the new generation hu-mice that harbor a
transplanted human immune system appear to be highly suitable. In work centered on SIV progenitor viral
evolution into HIVs, we and others found that hu-mice are susceptible to SIV-chimpanzee (SIVcpz) the progenitor
of HIV-1 and SIV-sooty mangabey (SIVsm) the progenitor of HIV-2. More recently, we discovered that hu-mice
are also permissive to macaque-derived SIVmac251, a widely used virus in NHP studies in the context of HIV
research. However, thus far no previous studies examined the human infection potential of more primitive SIVs
in the wild. Here we will evaluate two SIV strains, namely SIVrcm from red capped mangabeys and SIVmnd2
from mandrils, viruses from two distinct NHP species. These were previously studied in their native hosts wherein
they display high viral loads but are non-pathogenic. These two viruses are genetically linked to SIVcpz which is
the progenitor for HIV-1. While a full comprehensive study of these in vivo will be a complex undertaking, here
in this R21 grant of a limited budget and scope, we propose to start with the following simpler initial goals.
Aim 1: Investigate the potential for zoonotic transmission and sustained human infection by select SIVs, SIVrcm
and SIVmnd2 using a humanized mouse model.
Aim 2: Characterize key pathogenic attributes of the human adapted viruses for cell tropism, helper CD4 T cell
loss and capacity for sexual transmission.
Knowledge gained from here will shed light on the initial steps in cross-species transmission.

Public health relevance
Project Narrative: Cross-species transmission events from animal hosts gave rise to several deadly human pathogens including the recent SARS-CoV-2. Simian Immunodeficiency Viruses (SIV) in West and Central Africa gave rise to HIV-1 and HIV-2 from chimpanzee SIVcpz and sooty mangabey SIVsm, respectively. To prepare for future incidents such as these, the main goal of our proposed studies is to evaluate select SIVs, namely SIVrcm from red capped mangabeys and SIVmnd from mandrills for their potential for human transmission using a human surrogate hu- mouse animal model. This will be the first time these above viruses will be examined in an in vivo setting and the results from here will contribute to our knowledge on the initial steps in cross-species transmission and lay the ground work for using this model for evaluating other potentially zoonotic viral candidates in the future.